Calcium and Cell Function

PROJECT SUMMARY
The objective of the 19th FASEB Summer Research Conference on Calcium and Cell Function is to stimulate
discourse, seed new ideas, and promote collaborations to accelerate new discoveries on calcium signaling at
the basic and translational levels. Calcium is a universal signaling molecule controlling a vast array of cell
functions and thus plays an important role in the nervous, cardiovascular, and immune systems as well as many
other organs. Basic science discovery into the physiology of calcium transporters and binding proteins has been
accompanied by new insights into the pathophysiological role of abnormal calcium signals in numerous diseases,
such as Alzheimer’s disease, cardiac arrhythmias, autoimmunity, and cancer. A comprehensive understanding
of calcium signaling is essential for therapeutic development and is of high interest to scientists in academic and
biotechnology sectors. This FASEB Summer Research Conference will be held from July 6-10, 2025, in
Winnipeg, Canada. It will include three keynote addresses from leaders in calcium signaling: Masamitsu Iino
(Nihon University, Japan), Tobias Meyer (Weill Cornell Medicine), and Thomas C Sudhof (Stanford University).
It will be the most significant international meeting of the calcium field in 2025 and a forum where leading
scientists from around the world come together to present and discuss their latest and most important research.
The conference format comprises 8 sessions with 32 invited talks, 16 short talks selected from submitted
abstracts, two poster sessions, and three Career Development sessions. Scientific talks will cover a wide
spectrum of calcium signaling studies from basic to clinical research with a special emphasis on the nervous
system and aging biology. This highly inclusive conference program is crafted to foster interactions between
trainees, early career scientists, and established investigators. An important goal of this conference is to
empower the next generation of scientists. To achieve this goal, we seek funding to support the participation of
graduate students, postdoctoral researchers, and early career investigators, with a special emphasis on including
women, underrepresented minorities, and individuals with disabilities. The logistical arrangements of the
conference will provide numerous opportunities for organized and spontaneous interactions, providing junior
scientists opportunities to present their work, obtain valuable feedback from leaders in the field, and receive
guidance for career development. Since its inception in 1984, this biennial conference has been very successful
in bringing together leading investigators from diverse fields to share the latest and most exciting developments
in Calcium and Cell Function. It continues to serve as a unique platform for researchers to exchange ideas and
promote future collaborations in this dynamic field.

Public health relevance
PROJECT NARRATIVE Calcium is a versatile and ubiquitous signaling messenger that regulates a myriad of physiology processes and plays a critical role in numerous diseases such as Alzheimer’s disease, Parkinson’s diseases, hypertension, cardiac arrhythmias, stroke, asthma, and immunodeficiencies. A comprehensive understanding of calcium signaling is essential for therapeutic development and is highly relevant to human health, neuroscience research, and aging biology. The upcoming 19th FASEB Scientific Research Conference on Calcium and Cell Function will bring together basic and translational scientists from diverse scientific backgrounds and career stages to share the latest discoveries in calcium signaling to inspire innovative research among the next generation of scientists.